University of Washington Pediatric and Reproductive Environmental Health Scholars (UW PREHS)

ABSTRACT
There is a significant need for clinically trained practitioners with structured research training in environmental
health to translate research findings to clinical and policy realms. The overarching goal of the University of
Washington Pediatric and Reproductive Environmental Health Scholars (UW PREHS) career development
program is to bridge clinical training to research independence, through a mentored research experience in
pediatric and reproductive environmental health. The program integrates the outstanding research and training
opportunities at the University of Washington, forming a novel partnership among the Departments of Pediatrics,
Family Medicine, Obstetrics/Gynecology, Environmental & Occupational Health Sciences, and Epidemiology.
Nationally recognized PREH physicians-scientists and Pediatric Environmental Health Specialty Unit (PEHSU)
leaders, Dr. Catherine Karr and Dr. Sheela Sathyanarayana, are uniquely suited to lead the program to prepare
future leaders in PREH research and research to policy and practice translation. Our primary aims are to:
1. Recruit and train scholars in PREH science, rigorous research methodology and research skills.
2. Support scholars in completion of an impactful PREH research project.
3. Involve scholars in research translation practice activities through the NW Pediatric Environmental Health
Specialty Unit.
4. Establish and maintain a collaborative network of mentors for scholars to support their success in the UW
PREHS program and in transition to independence upon completion of the program.
Scholars will participate in a tailored career development program anchored in a set of core competencies
spanning four primary domains: 1) PREH content expertise, 2) Research methods development, 3) Practice
based research translation (PEHSU), and 4) Career development toward independence. Central structural
elements include mentor advised individualized learning plans, a novel PREH seminar series, involvement in
PEHSU consultation and outreach, and development and implementation of at least one research project.
Ongoing evaluation plans for scholars, mentors, and the program provides continual improvement for this new
program. A senior Advisory Committee will provide oversight of the program evaluation based on identified
benchmarks. The program is poised to recruit and train up to 6 scholars for 2-3 year periods each. Scholars will
be prepared to serve not only as scientists, but clinician-advocates and trusted and impactful voices on policy
and practices to improve environmental health conditions of children and families.

Public health relevance
PROJECT NARRATIVE This training program is designed to equip clinically trained scientists with expertise in the science of environmental exposures and their health effects in early life. The scholars will conduct research with senior mentors and develop skills in translation of science to answer real life questions regarding the role of environmental factors on pregnancy health and child health and how to reduce these risks.